Hormone mediated mechanisms of altered drug metabolism and transport in transgender adults

Dr. Lauren Cirrincione, an Assistant Professor at the University of Washington School of Pharmacy, is applying for a K23 award. Dr. Cirrincione’s career goals include making significant contributions to the field of hormone mediated drug interactions in transgender and gender diverse adults, specifically applying clinical pharmacology to transgender medicine. This grant will provide 1. expertise in probe substrate study methods and analysis and 2. longitudinal study design and 3. training to become an independent NIH-funded investigator with expertise in hormone mediated mechanisms of altered drug disposition and will address whether high-dose sex hormone therapy alters the disposition of other prescribed drugs. We will use a probe substrate-biomarker-protein activity framework to test differences in major drug handling proteins before and during estradiol treatment in vivo. Dr. Cirrincione will gain expertise in conducting mechanistic, clinical pharmacology studies in transgender adults. Data generated from this proposal will be used to advance clinical strategies to overcome changes in drug safety and efficacy in transgender adults and to increase available in vivo mechanistic data to establish the role of sex hormones on pathways of drug disposition.

Public health relevance
PROJECT NARRATIVE Worldwide nearly 25 million adults are part of a growing population of transgender people. Many transgender adults undergo hormone therapy as one part of the standard of medical care, but the effect of high dose sex hormone therapy on drug safety and efficacy has not been established. This project aims to evaluate the effect of estradiol treatment on the activities of cytochrome P450 3A and P-glycoprotein activities, two key drug handling proteins, to establish the effect of gender-affirming hormone therapy on drug disposition in transgender adults.